Implementation of Traumatic Brain Injury Screening in Behavioral Healthcare Organizations

PROJECT SUMMARY/ABSTRACT
Traumatic brain injury (TBI) is a major public health crisis for adults in the U.S. and globally. TBI can lead to
new or worsened substance use disorders (SUDs) and mental health comorbidities. Strikingly, TBI can
contribute to a 10-fold increase in the likelihood of unintentional overdose. TBIs are especially common among
adults who seek treatment for SUDs and other mental health comorbidities in behavioral health treatment
organizations. Effective and evidenced-based TBI screening methods exist (e.g., the Ohio State University TBI
Identification Method) that can be used by behavioral health providers to identify lifetime history of TBI among
clients; yet, providers have failed to adopt TBI screening into routine behavioral healthcare. Lack of TBI
identification could affect clinical care decisions and client outcomes. However, studies have yet to investigate
the determinants influencing TBI screening adoption among behavioral health providers in behavioral health
treatment organizations. The primary aims of this proposal are guided by the Theory of Planned Behavior
(TBP) and Roger’s Diffusions of Innovations Theory (DOI). I propose to conduct a prospective cohort study to
investigate whether provider-level characteristics from the TBP (attitudes, subjective norms, perceived
behavioral control, intentions), and innovation-level factors from the DOI (acceptability, feasibility, and
appropriateness of TBI screening) affect the adoption of TBI screening in behavioral health treatment contexts.
Using mixed methods, I propose three specific aims: (1) Examine the relationships between behavioral health
providers’ attitudes, perceived behavioral control, and subjective norms as predictors to TBI screening
intentions and examine whether intentions to adopt TBI screening predicts actual TBI screening behaviors at a
one month follow-up; (2) Investigate whether the acceptability, feasibility, and appropriateness of TBI screening
moderates the relationship between TBI screening intentions and actual screening behaviors; and (3)
Qualitatively assess the contextual determinants to TBI screening adoption through semi-structured interviews.
This proposed study is a necessary advancement toward the translation and implementation of existing and
effective innovations developed for adults with TBI within behavioral healthcare contexts. A training plan
consisting of individualized mentorship, formal coursework in advanced statistical techniques, and experiential
learning has been designed to ensure the proposed study is conducted rigorously and to develop my skills in
leading cutting-edge research as an independent investigator in the dissemination and implementation of
effective innovations for TBI.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) is a serious public health crisis that frequently co-occurs with substance use disorders (SUDs) and mental health comorbidities; however, TBI is under identified among adults who seek behavioral health treatment for these comorbidities. Although effective TBI screening innovations already exist that behavioral health providers can use to identify TBI among adults with SUDs and mental health conditions, providers have failed to adopt TBI screening into routine practice leading me to investigate whether provider- level characteristics and innovation-level factors affect TBI screening adoption in behavioral healthcare contexts. Results from this study can be used to inform implementation strategies aimed to increase TBI screening adoption in behavioral healthcare.